Epigenetic regulation of donor heart preservation mediated by Brd4

Project Summary/Abstract
While heart transplantation is the gold standard to treat patients with end-stage heart failure, there is a
shortage of donor hearts for recipients. Unfortunately, a minority of donor hearts on offer are accepted for
transplant. This can be for multiple reasons, but the risk of primary graft dysfunction (PGD) is a major factor in
turning down donor hearts. The risk of PGD is increased when cold static preservation time is >4 hours
although machine perfusion technique can prolong this time by several hours. Even with these advances, a
finite and significant geographical limitation is placed on organ matching. Expanding our molecular
understanding of cardiac preservation is needed to position the organ preservation field for leaps in therapeutic
advancements. Brd4 is a member of the bromodomain and extraterminal domain (BET) family of epigenetic
readers. It plays an important role in many cardiac diseases such as cardiac hypertrophy and coronary
atherosclerosis. Brd4 interacts with numerous factors that regulate transcription, histone modification,
chromatin accessibility and architecture. We show that human failing hearts and donor hearts with prolonged
preservation times have preferential short Brd4 isoform (Brd4-S) expression. We show that in-vivo knockdown
of Brd4-S in cardiomyocytes greatly improves ex-vivo donor heart function with prolonged preservation. We
also show that cold cardiac perfusion with histidine-tryptophan-ketoglutarate improves ex-vivo donor heart
function and is associated with a significantly reduced Brd4-S expression. We hypothesize that cold
preservation of donor hearts induces a switch towards Brd4-S expression leading to genome architectural
restructuring with epigenetic changes that promote cardiac injury. In Aim1, we will determine if increased
osmolality, cold perfusion and expression of splicing mediators contribute to Brd4-S expression during cardiac
preservation. We used ex-vivo perfusion and heterotopic transplant models to test these hypotheses. In Aim 2,
we will define the chromatin configuration induced by Brd4 isoforms during cold static cardiac preservation. We
will use mass spectrometry to identify Brd4-S binding partners in donor heart preservation. To characterize the
genomic landscape, we will examine the genome occupancy of Brd4-S and its cofactor, as well as histone
modification, chromatin accessibility and looping in preserved donor hearts with Brd4 isoform knockdown. To
determine the specific effects of cold perfusion on genomic organization, we will perform similar studies in cold
HTK-perfused hearts. In Aim 3, we will determine if inhibition of Brd4 improves the preservation quality of pig
and human hearts in a cold cardiac perfusion model. The proposed work will define Brd4-S's role in modulating
chromatin configuration during cardiac preservation and represents a preclinical organ preservation study of
combined Brd4 inhibition and cold HTK perfusion. This is expected to increase donor heart utilization and
expand the donor pool with broad implications for other solid organ transplants and ischemic pathologies.

Public health relevance
Project Narrative We found that decreasing the amount of a protein called Brd4-S in donor hearts used for transplantation greatly improves its function. Completing these studies will show how reducing Brd4-S will change the organization of genes in donor hearts and keep the heart healthy for transplantation. We will confirm these effects in pig and human hearts to improve heart transplant outcomes for patients.